Evaluation of Angiopoietins as Prognostic Markers of Kidney Allograft Structure and Function

Project Summary/Abstract
Kidney transplantation is the main therapy for end stage kidney disease (ESKD),1 however, 3-5% of grafts fail
yearly and only 50% remain functioning at ten years.2,3 The most common manifestations of graft loss are
poorly characterized histologic findings of interstitial fibrosis and tubular atrophy (IFTA), 4-7 which are present in
up to a third of biopsies 6-month after transplant.8 Furthermore, endothelial cell injury is common in kidney
transplantation due to ischemic injury during procurement,9 and leads to impaired vessel integrity and
peritubular capillary loss, which have been shown to lead to IFTA.9-12 In addition, vessel integrity has been
proposed to have a protective impact on kidney function by reducing microvascular leakage of albumin13, and
reducing the recipient alloimmune response to damaged endothelial cells.9, 10, 14, 15 For this reason, we propose
to evaluate two vascular markers in the Angiopoietin family capturing blood vessel integrity [Angiopoietin-1
(Angpt-1), and -2 (Angpt-2)] in the setting of deceased-donor kidney transplantation. Activation of the Angpt-1
receptor, Tie-2, maintains vessel stability and integrity, but Angpt-2, a competitive antagonist to Angpt-1,
interferes with the Angpt-1-Tie-2 axis, and promotes vessel leakage.16 The balance of Angpt-1: Angpt-2
production determines the integrity of blood vessels.17 The goal of this proposal is to evaluate if blood
vessel integrity as measured by Angiopoietins will be prognostic of short and long-term graft function
in an effort to identify pathways for future intervention. The candidate hypothesizes that maintaining
vessel integrity (as measured by Angpt-1 and Angpt-2) will be associated with less fibrosis, and better graft
outcomes. In aim 1, we will prospectively enroll deceased donor transplant recipients as well as use a pre-
existing cohort of recipients to evaluate and externally validate the associations of perioperative Angiopoietins
with 1-year graft function. In aim 2, we will evaluate if Angiopoietins measured at a single time point are
associated with long-term graft failure (mean follow up of about four years) by using bio-specimens from the
pre-existing FAVORIT trial. In aim 3, we will test the associations of perioperative Angiopoietins with tissue
pathology on 6-month graft biopsies using our prospective enrollment cohort. More specifically, we will
evaluate if Angpt-1 and -2 are associated with 6-month IFTA, peritubular capillary loss and vessel permeability
on histology. Understanding the role of vessel integrity as measured by Angiopoietins in allograft outcomes
may help identify pathways for future intervention and risk stratify recipients for more targeted trials and clinical
care.

Public health relevance
Project Narrative Non-functioning kidney grafts after deceased-donor kidney transplantation remain a significant problem, with about one thousand grafts failing yearly and only 50% remain functional after ten years. The current tools we have to predict graft failure are limited in providing pathways for future intervention, therefore this project aims to identify if recipient protein markers involved in blood vessel stability are associated with future graft function in an effort to identify pathways amenable to intervention. The mission of this project aligns well with the overall mission of the NIDDK, as we aim to understand pathways that influence recipient graft outcomes to be able to enhance graft quality and improve overall recipient health.